Role of lipid metabolism in CD8+ T cell ferroptosis

PROJECT SUMMARY
Recently, we made a novel and exciting discovery that tumors or the tumor microenvironment (TME) cause T-
cell dysfunction and death by inducing ferroptosis in T cells. We analyzed the sc-RNA-seq data of tumor-
infiltrating T cells from melanoma patients and discovered that tumor-infiltrating CD8+ T cells had significantly
increased expressions of genes associated with lipid peroxidation and ferroptosis compared to blood CD8+ T
cells from healthy individuals. More importantly, our unpublished studies further revealed that among different
CD8+ T cell subpopulations, effector memory (TEM) and terminally differentiated effector (TTE) CD8+ T cells are
more sensitive to tumor-induced ferroptosis. We examined tumor-infiltrating CD8+ T cells from the bone
marrow (BM; tumor bed) of patients with multiple myeloma. By separating the T cells into naïve, TTE or TEM
cells based on their expression of CCR7 and CD45RA, we found that TEM and TTE CD8+ T cells expressed
higher levels of lipid peroxidation- and ferroptosis-associated genes and were more sensitive to tumor-induced
ferroptosis compared to naïve CD8+ T cells although they expressed similar levels of CD36. Similarly, in
mouse melanoma and MM models, increased ferroptosis mainly occurred in tumor-infiltrating CD8+ TEM and
TTE cells but not in naïve CD8+ T cells from mice with large tumor burdens compared to those with small tumor
burdens. Our ex vivo studies confirmed that CD8+ TEM and TTE cells were more sensitive to tumor- or FA-
induced ferroptosis than naïve T cells and their production of cytotoxic cytokines such as IFNγ and TNFα was
inhibited. To elucidate the underlying mechanisms, RNA-seq was used and showed that CD8+ TEM and TTE
cells expressed a significantly lower level of 2,4-dienoyl-CoA reductase 1 (DECR1), a rate-limiting enzyme for
polyunsaturated fatty acid (PUFA) β-oxidation, compared to naïve CD8+ T cells. Knockdown (KD) of DECR1 in
naïve CD8+ T cells resulted in an increased PUFA expression and peroxisomal dysfunction and sensitized
them to tumor- or FA-induced ferroptosis than control T cells. Based on these novel findings, we hypothesize
that CD8+ TEM and TTE cells, due to uptake of more FAs and reduced expression of DECR1 and PUFA
oxidation, are sensitive to tumor/TME-induced ferroptosis, and inhibiting TEM and TTE cell ferroptosis may
effectively enhance the therapeutic efficacy of immunotherapy in cancer patients. Aim 1 will determine the
mechanism underlying tumor- or FA-induced ferroptosis in CD8+ TEM and TTE cells in TME. Aim 2 will elucidate
the role and mechanisms of tumor and TME accumulation of FAs and induction of lipid peroxidation in CD8+
TEM and TTE T cells and Aim 3 will inhibit CD8+ TEM and TTE cell ferroptosis to enhance the efficacy of cancer
immunotherapies. Accomplishing these aims will provide us with in-depth understanding of the mechanisms
underlying how tumors and the TME induce T cell lipid peroxidation and how ferroptosis mediates T cell
metabolic malfunction and death. Understanding these mechanisms is extremely important and will greatly
assist us in developing novel therapeutic approaches to target T cell lipid metabolism and TME to significantly
improve the efficacy of cancer immunotherapy.

Public health relevance
Project Narrative We will determine 1) how tumors and the tumor microenvironment accumulate fatty acids and use them to induce lipid peroxidation in tumor-infiltrating CD8+ TTE or TEM cells; 2) how lipid peroxidation induces CD8+ TTE or TEM cell ferroptosis and dysfunction in tumor beds, and 3) explore new methods to counteract fatty acid effects and to restore T cell function in cancer patients. We hypothesize that inhibiting T cell ferroptosis will effectively enhance the therapeutic efficacy of immunotherapy in cancer patients. Completing this project will allow us and others to identify novel therapeutic targets and develop new methods to improve the efficacy of current cancer immunotherapies.